Targeting a novel neural circuit to modulate trigeminal neuropathic pain

Project Summary:
Trigeminal neuropathic pain is a debilitating condition and represents a challenge to clinicians because
such pain is often refractory to currently available therapies. The brain neural circuit mechanism underlying this
type of pain remains poorly understood. We will address the knowledge gap in this project. The objective of this
project is to dissect a novel neural circuit for the modulation of trigeminal neuropathic pain. In my preliminary
study, using a revolutionary approach called “Targeted Recombination in Active Populations (TRAP)”, I identify
that neurons in the anterior paraventricular thalamic nucleus (aPVT) are markedly activated by chronic
constriction injury of the infraorbital nerve (CCI-ION). By anterograde and retrograde viral tracing, I show that
the TRAPed aPVT neurons directly project to anterior cingulate cortex (ACC). Moreover, I found that optogenetic
excitation of the TRAPed aPVT neurons enhances CCI-ION-induced trigeminal neuropathic pain and
optogenetic silencing of the aPVT neurons attenuates such pain. My preliminary results suggest that aPVT
neurons and their projection to ACC could be involved in the modulation of trigeminal neuropathic pain. In this
project, I will further interrogate the role of aPVT-ACC pathway in trigeminal pain modulation. My hypothesis is
that specific manipulation of aPVT-ACC pathway can modulate trigeminal neuropathic pain in an activity-
dependent manner: Specific activation of aPVT-ACC pathway enhances trigeminal neuropathic pain through
increasing neuronal activity in the ACC; oppositely, specific inhibition of aPVT-ACC pathway produces pain relief
by decreasing neuronal activity in the ACC. To address this central hypothesis, I will use multidisciplinary
approaches to conduct the following studies in two specific aims. In Aim 1, I will determine the role of aPVT-ACC
pathway in trigeminal pain modulation by investigating the effect of optogenetic manipulation of this pathway on
CCI-ION-induced trigeminal neuropathic pain. Both evoked and spontaneous pain behaviors will be measured
with von Frey test and real-time place preference assay, respectively. In Aim 2, I will characterize aPVT-ACC
pathway-mediated regulation of neuronal activity in the ACC during trigeminal neuropathic pain using miniatured
microscope-based in vivo calcium imaging in freely moving mice. Collectively, I expect to show that the aPVT-
ACC pathway is critical for trigeminal pain modulation. The proposed research is significant since it will advance
our understanding of brain neural circuitry for pain modulation. The proposed studies are innovative since these
studies will reveal a previously unrecognized neural circuit that underlies trigeminal pain modulation.

Public health relevance
Project Narrative: In this project, I focus on the interrogation of aPVT-ACC pathway in the modulation of trigeminal neuropathic pain. I will demonstrate the underlying circuit mechanisms and provide experimental evidence to define how the activated aPVT neurons modulate trigeminal neuropathic pain through regulating neuronal activity in the ACC. My long-term goal is to reveal neural circuit mechanisms for different types of chronic pain and then collaborate with electrical engineers to create a wireless closed-loop neuromodulation device for chronic pain management.